Salivary Zinc modifies Histatin 5 activity towards C. albicans survivor cells and commensalism

Candida albicans is an opportunistic fungus and the causative agent of oropharyngeal candidiasis (OPC) that
develops in a wide spectrum of immunocompromised people. However, in healthy populations, C. albicans is a
commensal organism that is part of the oral microbiome. Salivary Histatin 5 (Hst 5) is a highly abundant salivary
protein that is well characterized for its fungicidal activity. Hst 5 contains six histidine residues that comprise two
zinc-binding motifs. Zinc (Zn) is the most abundant salivary metal, and Zn binding with Hst 5 causes
oligomerization of Hst 5 that alters it fungicidal activity. We found that treated C. albicans cells exposed to low
doses of Hst 5/Zn2+ recover as phenotypically different “survivor cells” that have altered cell wall composition,
increased adhesion and reduced invasion of oral epithelial cells (OECs) along with dampened OEC inflammatory
responses. Our hypothesis is that the major role of salivary Hst 5 when bound with zinc in vivo is to promote
commensalism of oral C. albicans thus maintaining this organism as member of the healthy oral microbiome.
We will test our hypothesis with following Specific Aims: 1. Determine whether cell wall changes in Hst5-Zn
induced survivor cells modify susceptibility to cell wall targeting antifungal drugs or alter binding with their
microbial mucosal binding partners. Aim 2. Determine how survivor cells modulate OECs inflammatory
responses and alter Candida colonization along with mucosal binding partners in vitro. Aim 3. Test
commensalism of survivor cells in vivo using a murine model of oral candidiasis by altering ambient oral zinc
levels. Our goal is to fully understand the how salivary Hst 5-Zn complexes might promote commensalism and
maintain a healthy homeostasis with mucosal oral binding partners, so that future clinical studies might be
directed to therapeutic oral rinses that alter zinc levels to improve the function of Hst 5.

Public health relevance
Narrative Candida albicans is a fungus that causes oropharyngeal candidiasis (thrush) in some people but is tolerated without symptoms in the mouth and gut in most healthy individuals. Salivary Histatin 5 (Hst 5) is an abundant zinc-binding antifungal peptide that effectively kills C. albicans without zinc but produces of C. albicans survivor cells with a commensal phenotype when complexed with zinc. We will examine how zinc-Hst 5 complex induced changes to C. albicans (survivor cells) alter their susceptibility to antifungal drugs, interactions with interspecies mucosal binding partners, and dampen inflammatory signaling in the oral mucosa to understand how Zn-Hst 5 modulates fungal commensalism with the goal of tuning the activity of Hst 5 by therapeutic changes in salivary zinc levels.